NMR-resolved dynamics of C. difficile metabolism

Abstract: Clostridioides difficile is the most prevalent cause of hospital associated infections
(HAIs). As an obligately anaerobic pathogen, C. difficile can consume diverse carbon sources to
support gut colonization and infection. In particular, glycolytic and Stickland amino acid
fermentation pathways have been shown to support rapid growth, a finding that also occurs after
antibiotic treatment elevates availability of these nutrient sources by removing competitive
commensal species. However, the metabolic pathways of obligately anaerobic bacteria remain
ill-defined, limiting capacity to identify preventive and therapeutic interventions that target C.
difficile’s core physiology. To address these limitations, we will employ carbon-13 (13C) NMR of
C. difficile’s dynamic metabolism to inform a genome-scale metabolic model and clearly define
metabolic integration points among energy-generating glycolytic and amino acid fermentation
pathways. Findings will be evaluated in targeted genetic mutants and with combinations of
fermentable carbon sources to evaluate their impact on pathogen growth and virulence.

Public health relevance
Narrative Clostridioides difficile has a complex metabolism that supports gut colonization as well as capacity to rapidly expand after antibiotic ablation of the commensal microbiota promotes host-based release of nutrient sources via toxin-mediated damage to mucosal surfaces. Using novel methods in nuclear magnetic resonance (NMR) we will clearly define the real-time metabolism of living C. difficile cells, under anaerobic and reducing conditions, to inform metabolic targets in carbon and nitrogen metabolism. Findings will inform functional studies to identify therapeutic targets.